Proteogenomic studies to understand mechanisms and drivers of resistance to immunotherapies

Project Summary/Abstract
Melanoma is the deadliest form of skin cancer. Its incidence is on the rise with 106,000 new cases expected in
the U.S. in 2021. Immune checkpoint inhibitors (ICIs) have revolutionized the treatment of early and advanced
melanoma, with concurrent anti-CTLA-4 and anti-PD-1 monoclonal antibodies demonstrating a response in
~50% of patients, including highly durable responses. Unfortunately, there are no adequate biomarkers to predict
response to single agent or combination ICI, and dual checkpoint blockade is associated with significant grade
3/4 immune-related adverse events (irAEs) in ~55% of patients. The goals of our PTRC are designed to address
two unmet clinical needs: (i) improve our understanding of mechanisms of resistance to ICIs to design more
effective immunotherapies and combinations, and (ii) identify potential biomarkers to select patients
appropriately for single agent vs combination immunotherapies and to predict and monitor irAEs. In our
Preclinical Arm, we will perform integrated proteogenomic analysis of clinically annotated, pre-treatment biopsies
from melanoma patients who received ICI. The data will be analyzed in the context of clinical annotations to
refine an existing signature of melanoma ICI response identified by our team and to further elucidate mechanisms
of ICI response/resistance and signatures associated with irAEs. In our Clinical Arm, we will analyze clinical trial
biospecimens using MRM-based assays to confirm & extend findings generated in the Preclinical Arm.

Public health relevance
Project Narrative Melanoma is the deadliest form of skin cancer, and its incidence is on the rise with 106,000 new cases expected in the U.S. in 2021. Although immunotherapies are revolutionizing the treatment of melanoma, they are associated with significant toxicity, and there are no clinically useful biomarkers to predict which tumors will respond to single agent or combination immunotherapies. This project will use an integrated proteogenomics approach to improve our understanding of mechanisms of resistance to ICIs to design more effective immunotherapies and combinations, and to identify potential biomarkers to select patients appropriately for single agent vs combination immunotherapies, and to predict and monitor irAEs.